PROACTIVE PREVENTION IN DIABETES CARE--IN MANAGED CARE

Description (Taken directly from the application): In the United States, managed care is growing rapidly. The membership of managed care organizations (MCOs) now exceeds 50 million people and may grow by an additional 50 million by the year 2,000. The most rapidly growing type of MCO is that based on the Individual Practice Association (IPA) model. The absence of data attesting to the effectiveness and cost-effectiveness of comprehensive diabetes management within an IPA model MCO constitutes a major barrier to the introduction of such care in this type of health care system. The hypothesis of this project is that within the context of an IPA-model MCO, the system-wide identification of members with diabetes and their enrollment in a comprehensive diabetes management program that includes comprehensive provider profiling and diabetes health management will improve the process, outcomes, and cost-effectiveness of care. The Specific Aims of the project are: 1. develop and implement a medical information system-based method to identify members with previously diagnosed diabetes in an IPA model MCO; 2. randomize patients by practice to comprehensive versus usual diabetes management, and to compare the processes and outcomes of care in the two randomized groups; and 3. apply an economic model to these data to compare the cost and cost-effectiveness of comprehensive versus usual management. We anticipate that the results of this project will improve the ability of IPA-model MCOs and medical care providers to identify patients with previously diagnosed diabetes. Comprehensive health management for people with diabetes in an IPA-model MCO will address many of the barriers to care that exist in the present medical care system, and will represent a new and potentially cost-effective strategy for diabetes management in a rapidly growing type of health care system.